Biostatistics and Bioinformatics Core

Biostatistics and Bioinformatics Core PROJECT SUMMARY: The overall objective of the Biostatistics and Bioinformatics Core (Core B) is to provide comprehensive expertise in biostatistical analysis, research design, and informatics to all participants of the SPORE in Prostate Cancer at Northwestern University, University of Chicago and NorthShore University HealthSystem. The Specific Aims of the Core are: • Specific Aim 1: To maintain and enhance the pre-clinical, clinical and tissue databases of the SPORE • Specific Aim 2: To provide state of the art experimental design, epidemiological and biostatistical expertise to all of the SPORE projects • Specific Aim 3: To conduct data collection and data analysis for SPORE projects • Specific Aim 4: To provide infrastructure and expertise for inter-SPORE and other scientific collaborations.

Public health relevance
Biostatistics and Bioinformatics Core PROJECT NARRATIVE: The Core will provide expertise in study design, research methods, data quantification, statistical methods and statistical computing. This Core will work closely with all SPORE personnel in the preparation of papers for presentation and manuscripts for publication.